Measuring the Impact of Price Ceiling Controls: A Case Study of Insulin Out-of-Pocket Caps

PROJECT SUMMARY
Over 30 million Americans have type 1 diabetes (T1D) or type 2 diabetes (T2D), a disease with significant
effects on morbidity and mortality1 that disproportionately affects non-White adults and low-income
populations.2,3 For diabetes patients, tight glycemic control can reduce the risk of micro- and macrovascular
complications, ultimately reducing lifetime health care costs and improving longevity and quality of life.4 To
achieve tight glycemic control, patients rely on various medications and different formulations of insulin.5 List
prices for insulin more than tripled from 2007 to 2018.6 The list price is often used to determine cost sharing
amounts for patients. In 2017, an estimated one-quarter of insulin-using individuals with diabetes reported
insulin-underuse due to out-of-pocket costs.7,8 Furthermore, insulin-underuse is more common among Black
and Hispanic populations,9 a fact that raises equity concerns regarding health care access and outcomes.
State policymakers have responded to insulin affordability issues by capping insulin out-of-pocket costs.
Colorado was the first state to do so on January 1, 2020.10 Following Colorado, an additional 24 states plus
Washington, DC have passed such caps.11 These caps standardize the price patients pay for insulin and may
enable T1D and T2D patients to switch to clinically preferred products that were previously unaffordable. Yet,
capping out-of-pocket costs for insulin and not other medications to manage T2D may induce patients with
T2D to use insulin rather than more expensive medications with better cardiorenal protective effects. We
explore the market effects of insulin out-of-pocket caps through 3 aims:
• Aim 1. Measure the effect of state-level caps on insulin out-of-pocket costs on changes in the use of
clinically preferred insulin products to treat diabetes.
• Aim 2. Measure the effect of state-level caps on insulin out-of-pocket costs on changes in the use of
clinically preferred non-insulin products to treat type 2 diabetes.
• Aim 3. Identify key patient considerations regarding choice of treatments for managing T2D given a state-
level cap on insulin out-of-pocket costs.
We will accomplish Aims 1 and 2 with difference-in-differences analyses using a 25% sample of claims and
enrollment data from IQVIA PharMetrics Plus for the time period of 2018-2022. We will accomplish Aim 3 using
qualitative focus groups. Aim 3 will inform interpretation of the findings from Aim 2 by, for example, providing
preliminary evidence for whether patient preferences for T2D treatment diverge from clinical recommendations
due to affordability considerations. In addition to providing specific findings in the context of an insulin out-of-
pocket cap and diabetes care, the output from this grant will provide a methodology we can apply to measure
the effects of other price ceiling policies, such as Medicare's annual out-of-pocket cap for Part D drugs.

Public health relevance
NARRATIVE To address public concern about high prescription drug prices and access to medications, legislators have adopted price ceiling control policies, such as monthly out-of-pocket caps for insulin, annual out-of-pocket caps for prescription drugs, and drug affordability boards with the power to set payment ceilings for high-cost prescription drugs. While price ceiling control policies are promising tools to improve access to and utilization of the targeted medications, they may have broader market effects. Using state-level insulin out-of-pocket caps as a case study, we examine whether price ceiling control policies lead to changes in the use of clinically preferred products to manage diabetes.